OPERATIVE RISK, MORTALITY AND QUALITY ASSURANCE IN CARDIAC SURGERY

Perform univariate and ultivariate analyses on data collected to VA Medical Center patients undergoing cardiac surgery to identify predictors of death and serious complications, assess quality of care by developing multivariate model calculate the expected operative mortalities for each participating medical center [logistics].